Identification by High Throughput Screening of Inhibitors of the Mycobacterium tuberculosis ESX-1 and ESX-5 Type VII Secretion Systems – critical virulence determinants and novel drug targets

PROJECT SUMMARY/ABSTRACT
Tuberculosis (TB) is a serious global health problem, causing ~10.6 million active cases and 1.3 million
deaths/year. Better drugs are urgently needed to shorten the burdensomely long treatment course and to
combat the global emergence of drug resistant strains of Mycobacterium tuberculosis (Mtb), the causative
agent. Attractive and novel targets not previously exploited for new drug development are the newly identified
Type 7 Secretion Systems (T7SSs), designated ESX-1 to ESX-5, that transport factors through the Mtb
hydrophobic cell wall that are essential to Mtb viability and virulence. Here, in a collaborative study involving
researchers in a laboratory with years of experience studying the cell biology and pathogenesis of Mtb and
developing novel drug regimens to combat TB and the Director of the state-of-the-art Molecular Screening
Shared Resources (MSSR) facility at UCLA, we propose to identify small molecule inhibitors of the Mtb T7SS.
In preliminary work, we have developed split-luciferase based high-throughput assays targeting a critical step
in the function of the ESX-1 and ESX-5 secretion systems. We now propose to use these assays to screen the
extensive small compound molecule libraries (> 300,000 compounds) at the UCLA MSSR to identify small
molecule inhibitors of Mtb ESX-1 and ESX-5. Hit compounds will be retested in orthogonal assays to confirm
their capacity to block Mtb T7SS secretion and Mtb growth in human macrophages in cell culture; ESX-5
inhibitors will additionally be evaluated for capacity to block Mtb growth in broth culture. We anticipate that
validated hit compounds will fall into several series of structurally related compounds. We shall choose 5 - 10
of our most potent structural series for analoging (at least 20 analogs per series). We shall test the potency of
the analogs in dose response in our original and orthogonal assays and assess their performance in in vitro
ADMET assays. These studies will identify the most promising lead compounds with the highest therapeutic
ratio for further development. Such compounds will serve as vital tools for additional studies of the role of the
T7SS in Mtb pathogenesis as well as lead compounds for development of a new class of antibiotics to treat
TB.

Public health relevance
PROJECT NARRATIVE/RELEVANCE TO PUBLIC HEALTH Tuberculosis is a major global health problem whose treatment is unusually protracted and complicated by the emergence of multi-drug and extensively drug resistant strains of Mycobacterium tuberculosis, the causative agent, and hence new and better drugs to treat tuberculosis are urgently needed. This project seeks to identify small molecules that block the mycobacterial ESX-1 and ESX-5 Type VII secretion systems (T7SSs), as these systems are essential to the capacity of the bacteria to grow and cause disease and constitute novel drug targets. We shall screen extensive libraries of chemical compounds to identify those that block the function of the ESX-1 and/or ESX-5 T7SS and then confirm the capacity of these inhibitors to block the capacity of the bacteria to replicate within human host cells and the capacity of ESX-5 inhibitors additionally to block growth of the bacteria in broth culture, thereby providing proof of principle for development of a new class of antibiotics to treat tuberculosis.